Designing induction therapies to target memory T cells in high risk recipients

ABSTRACT
Antibody-mediated lymphocyte depletion is a common strategy to eliminate donor-reactive T cells in transplant
recipients. However, memory T cells are more resistant to depletion and have been associated with acute
rejection episodes in transplant recipients treated with polyclonal rabbit anti-thymocyte globulin (ATG) or anti-
CD52 mAb. Understanding the mechanisms and composition of T cells reconstituted in lymphopenic transplant
recipients is thus critical for the rational use of lymphoablative therapies and for improving their graft-prolonging
efficacy. The ultimate goal of our studies is to develop approaches that minimize homeostatic expansion and
shift the balance towards thymopoiesis, thus avoiding over-immunosuppression. During the previous funding
cycle, we used a murine ATG analog (mATG) in a mouse heart allograft model to establish that homeostatic
reconstitution of the entire T cell compartment is driven by depletion-resistant memory CD4+ T cells via B cells
and CD40/CD154 pathway. While cognate TCR-pMHC interactions between B cells and T cells were
dispensable, we identified posttransplant inflammation and B cell-derived cytokines IL-1β, IL-6 and IL-27 as key
factors facilitating homeostatic T cell recovery. Our preliminary data indicate that signaling through pattern
recognition receptors TLR4, TLR9 and a Macrophage-inducible C-type lectin (Mincle, or Clec4e) is required to
initiate B cell production of proinflammatory cytokines. We further identified innate-like marginal zone (MZ) B
cells acting as initial sensors of posttransplant inflammation in lymphopenic recipients. Genetic deficiency or
specific depletion of MZ B cells markedly delays T cell reconstitution in mATG treated heart allograft recipients.
We hypothesize that inflammation induced by transplantation at the time of lymphoablation promotes rapid T cell
reconstitution. DAMPs released by the graft activate B cells to secrete proinflammatory cytokines that further
amplify B cell activation and directly enhance T cell proliferation. In particular, MZ B cells activated via C-type
lectin receptor Mincle and TLRs act as initial sensors of posttransplant inflammation facilitating proinflammatory
functions of follicular B cells. Therefore, the homeostatic recovery of memory T cells and ensuing allograft
rejection may be decreased by minimizing DAMPs signaling or by targeting MZ B cell activation and functions.
We will test this hypothesis in two Specific Aims: Aim 1. To test the role of MZ B cells as primary sensors of graft
tissue injury in lymphopenic recipients. Aim 2. To investigate the mechanisms by which C-type lectin receptor
Mincle facilitates B cell proinflammatory functions after mATG lymphoablation.
The proposed studies will mechanistically dissect how inflammatory pathways triggered by allograft
ischemia/reperfusion injury drive rapid reconstitution of depletion-resistant memory T cells. Based on these
insights, we will test the efficacy of several clinically relevant approaches for inhibiting recovery of pathogenic
donor-reactive memory T cells and prolonging heart allograft survival in ATG treated recipients.

Public health relevance
PROJECT NARRATIVE While antibody-mediated lymphocyte depletion is commonly used to eliminate donor-reactive T cells in transplant recipients, its impact on long-term transplant survival remains controversial. The proposed studies will investigate how inflammatory pathways triggered by allograft transplantation drive rapid reconstitution of pathogenic memory T cells. Based on the gained mechanistic insights, we will test several clinically relevant approaches for prolonging heart allograft survival in recipients treated with lymphoablation.